Mitochondrial Zn2+ accumulation and the induction of ischemic neurodegeneration

7. Project Summary/Abstract Therapy for ischemic brain injury is poor in part because of our limited understanding of mechanisms leading to neuronal loss. While roles of excessive glutamate release and neuronal Ca2+ accumulation have been much studied, recent evidence implicates critical contributions of another divalent cation, Zn2+. After ischemia or prolonged seizures, free Zn2+ accumulates in neurons, and observations that Zn2+ chelation is protective implicates a role in neuronal death. Culture studies have revealed that exogenously applied Zn2+ can enter neurons and accumulate in mitochondria, powerfully disrupting their function. However, little is known about mechanisms of injury caused by the accumulation of endogenous Zn2+ in native brain tissues. Using acute hippocampal slices subjected to oxygen glucose deprivation (OGD) to model ischemia, we recently made the first simultaneous measurements of cytosolic Zn2+ and Ca2+ changes, and found that Zn2+ accumulation is an early event in hippocampal pyramidal neurons that precedes and contributes to a subsequent sharp and terminal Ca2+ deregulation event, causatively linked to loss of membrane integrity. More recently, we have found that the acute deleterious effects of Zn2+ seem to result specifically from its uptake into mitochondria via the mitochondrial Ca2+ uniporter (MCU). In further and ongoing slice studies, we find evidence for major differences between sources of the Zn2+ that accumulates in hippocampal CA1 and CA3 pyramidal neurons and contributes to acute OGD induced damage, with considerable Zn2+ accumulating in mitochondria of CA1 but not of CA3 neurons at delayed time points after a sublethal episode of OGD. These differences in Zn2+ contributions between CA1 and CA3 may bear upon the differential vulnerabilities of these neurons, in disease conditions, with CA1 neurons preferentially degenerating after transient global ischemia, and CA3 neurons after recurrent limbic seizures. This proposal continues ongoing studies, generally organized around a Hypothesis: Mitochondrial Zn2+ accumulation is an early event in ischemic neuronal injury, which causes disruption of mitochondrial function and contributes to cell death. Aim I applies advanced imaging techniques to cultured neurons to: 1. Examine neuronal Zn2+ dynamics; 2. Quantitatively examine the relationship between cellular Zn2+ and Ca2+ entry, cytosolic Zn2+ buffering, mitochondrial Zn2+ accumulation, mitochondrial dysfunction and neuronal cell death; and 3. Determine treatment approaches and the time windows for their delivery that can rescue the neurons after Zn2+ loading. Aim II applies imaging techniques to acute hippocampal slices to further clarify sources and mitochondrial effects of Zn2+ in CA1 and CA3 neurons, and to study events occurring after restoration of O2/glucose (“reperfusion”) that may be amenable to beneficial therapeutic interventions. It is hoped that these studies will provide mechanistic insights that will aid the development of new and effective therapeutic interventions to be delivered either during the acute phase of ischemia or upon reperfusion, that will disrupt the pathological cascade, enabling improved outcomes.

Public health relevance
8. Project narrative Despite being a cause of tremendous morbidity to the aging population, treatment of stroke is presently poor in part because of limited understanding of the events set in motion by ischemia that culminate in loss of function and nerve cell death. In this study, we use in vitro paradigms (dissociated culture and hippocampal slice preparations) to follow up on compelling leads from ourselves and a large number of others investigators over the past two decades highlighting Zn2+ accumulation in neurons as a critical but inadequately understood early event in brain ischemia that plays an integral role in the initiation of downstream injury cascades. Proposed studies systematically examine where the Zn2+ comes and how it acts in these critical early stages, and seek to leverage these insights in the early preclinical examination of interventions that could be delivered either during acute ischemia, or more significantly from a therapeutic standpoint, in the reperfusion period after restoration of blood flow. We hope that the studies will ultimately lead improved understanding of mechanisms triggering delayed injury after ischemia and suggest potential new approaches for targeting them.